Transgenic mouse models of disease to test an innovative OMV-based vaccine for protection against the pathogenic Neisseriae

The human-specific pathogen Neisseria gonorrhoeae (Ngo) causes the sexually transmitted infection gonorrhea. Ngo
frequently causes infections localized to the urogenital tract in both males and females, though manifestations such as
pelvic inflammatory disease, ectopic pregnancy and infertility can result from untreated infection. Rapid evolution of drug
resistance by Ngo has led to its identification as an urgent threat and hastens the need to identify an efficacious vaccine.
Our vaccine strategy targets conserved outer membrane transport proteins that provide critical growth-supporting
functions during human infection. The outer membrane transport system (TbpA/B) that enables Ngo to employ human
transferrin as an iron source is necessary for and produced during human infections. The highly conserved zinc
transporters (TdfH and TdfJ) are also expressed in vivo. We have observed that antibodies that target these receptors will
both starve the bacteria of these essential nutrients and facilitate bacterial engulfment by opsonophagocytosis and
complement-dependent killing. While surface-exposed, these proteins are not targeted when in the context of standard
outer membrane vesicle (OMV)-based vaccines because they are not expressed during normal in vitro growth conditions.
When they are present, their binding to their respective host proteins can inhibit the immune response. In this application,
we propose to generate OMV vaccines that express binding-defective derivatives of these proteins and test their ability
to protect against infection in ‘humanized’ transgenic mice that express the human ligands for these transport systems.
We hypothesize that a vaccine that elicits a response against each of these surface antigens will fully protect against all
gonococcal infections, and expect that they will also prevent meningococcal infection due to high levels of sequence
identity in these transporters between the species. These studies are significant because development of a cross-
protective vaccine to prevent diseases caused by the pathogenic Neisseriae are critically needed and the approach that
we propose has the potential to protect against both species, making it more generally acceptable than an Ngo-focused
vaccine. These studies are innovative because OMVs from recombinant strains that lack immune-regulatory components
will be used to elicit a response that targets multiple binding-defective but otherwise highly conserved proteins required
for infection, and because these are being tested using state-of-the-art, unique animal models in which the human metal
binding proteins that the neisserial proteins target are endogenously expressed. The specific aims of this proposal are:
Aim 1: Use transgenic mice producing human transferrin, calprotectin and psoriasin to discern in which infected tissues
their neisserial outer membrane transport systems contribute to colonization and disease. Aim 2: Exploit a combination
of immunization with iron and zinc-starved gonococci and a unique repertoire of neisserial outer membrane transporter-
specific polyclonal and monoclonal antibodies to understand how these contribute to protection against Neisseria disease.
Aim 3: Employ OMVs from genetically engineered LOS-modified, Rmp- and Opa-deficient Ngo strains that overproduce
the outer membrane transporters to elicit cross-protective immune responses in transgenic animals. Overall, these
innovative studies will target essential nutrient acquisition systems to develop an effective pan-Neisseriae vaccine.

Public health relevance
Neisseria gonorrhoeae causes the sexually-transmitted infection, gonorrhea, for which there are dwindling treatment options and no protective vaccine. OMV-based vaccines have shown promise in terms of eliciting efficacious immune responses that protect against N. meningitidis and to some degree, cross-protection against N. gonorrhoeae. This application proposes to use innovative humanized models of gonococcal infection to discern the virulence contributions of outer membrane metal transport systems and their potential as a pan- Neisseria protective vaccine in an OMV formulation.